Maternal exercise during lactation to ignite infant metabolism

PROJECT SUMMARY/ABSTRACT
Breastfeeding reduces risk of childhood obesity and diabetes, but the mechanisms remain unclear. We recently
identified that 12,13-diHOME, a signaling lipid crucial for activating brown adipocyte thermogenesis, is present
in human milk. We reported that higher concentration of 12,13-diHOME in milk at 1-mo postpartum was
associated with lower infant fat mass. Furthermore, milk levels of 12,13-diHOME, and other metabolites involved
in adipocyte thermogenesis, were significantly increased after maternal exercise. Thus, we hypothesize that
maternal exercise during lactation protects against childhood obesity by upregulating thermogenic metabolites
and lipids in milk. We propose to systematically compare the acute versus chronic effects of maternal exercise
on human milk composition, and to test how maternal exercise-induced changes in milk influence metabolic
activity and body composition in infants. In Aim 1, we will measure changes in thermogenic metabolites and
lipids in human milk in response to a single exercise session and to an 8-week physical activity intervention. We
will randomize 100 exclusively breastfeeding mother-infant pairs to either an “Active” group (targeting >8,000
steps/day) or a "Control” group (standard of care), with daily activity monitoring from 1 to 3 months postpartum.
All participants will complete a supervised acute exercise bout at 1 and 3 months postpartum. Milk samples
collected before and after exercise will be used for metabolomic and lipidomic analyses. In Aim 1A, we will
determine how milk composition is affected by the activity intervention by comparing the “Active” vs. “Control”
groups. The goal of Aim 1B is to measure acute changes in milk composition in response to a single exercise
bout. We will also determine whether the 8-week activity program alters milk composition responses to the single
exercise session. In Aim 2, we will test whether chronic and acute maternal exercise alterations of milk-derived
mammary epithelial cells (MECs) mediate adaptive changes in human milk composition. Building on our
preliminary data showing that mRNA signatures in MECs are altered by maternal obesity and exercise, we will
analyze mRNA signatures and protein content for key enzymes and signal transduction pathways for lipid and
nucleotide sugar metabolites, using samples from the acute and chronic activity experiments. In Aim 3, we will
link maternal exercise-induced changes in human milk to metabolism and body composition in infants of
participants recruited in Aim 1. The goal of Aim 3A is to define the immediate metabolic impact on infants fed
with “after-exercise milk” relative to a feeding with “before-exercise milk”. This will involve measuring
thermogenic activation via infrared thermography, energy expenditure with indirect calorimetry, and analyzing
the infant plasma metabolome and lipidome at 1 and 3 months. In Aim 3B, we will compare adiposity in infants
of mothers in the Active vs. Control groups in the first year of life; outcomes will include body composition (Pea
Pod and DXA), beige/brown fat anatomy (MRI), and infant growth (z-BMI). These studies will provide key data
to guide a larger clinical trial of exercise during lactation.

Public health relevance
PROJECT NARRATIVE Breastfeeding reduces the risk of childhood obesity, but the specific compounds within human milk that affect infant development and metabolism are only beginning to be understood. This project will study the impact of maternal exercise on the composition of human milk and on the early origins of obesity risk during the first year of life.